Rwanda 912: an mHealth Application to Improve Quality of Trauma and Emergency Care in Kigali, Rwanda

PROJECT SUMMARY/ABSTRACT
Prompt, high-quality emergency care saves lives. Despite this, formal trauma and emergency medical systems
are rare in most LMICs. In this application, we propose to establish “Rwanda912” as an innovative mHealth
platform to improve the existing prehospital system by accurately locating patients and facilitating communication
between dispatch, ambulance and emergency triage staff. We will conduct this study in two phases: an R21
phase to establish baseline outcome measures, and develop and test the intervention, and an R33 phase to
evaluate the intervention using a type 2 hybrid effectiveness/implementation design. In the R21 phase, we will
establish baseline prehospital care time-based outcomes using a pilot software application to collect time data
and exploratory clinical outcomes for trauma patients using the existing WHO Trauma Registry in Kigali, Rwanda.
Then will develop the innovative Rwanda912 mHealth platform using the accelerated-create-to-sustainment
(ACTS) model and assess for accuracy, reliability and stakeholder acceptability through a mixed-methods
approach. In the R33 phase, we will implement and optimize the Rwanda912 platform for the clinical setting
again using the ACTS model and then evaluate the implementation to determine acceptability, feasibility and
fidelity using the Proctor framework. We will determine effectiveness based on an anticipated 10% reduction in
total prehospital time with 90% power using a Type 2 hybrid implementation/effectiveness design. We will use
an interrupted time series statistical design to evaluate the primary outcome based on one year of ambulance
deployments pre and post implementation (n=6600). This project will leverage our established collaboration in
this setting, foster mHealth development and research capacity in four Masters student, one PhD student and
four software developers in Kigali. This will create a foundation for future funding applications to develop,
implement and evaluate additional platform features such as a public interface. Study findings will serve as a
model for developing a similar communication platform to support pre-hospital emergency care in other LMIC
settings.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH Nearly half of the preventable deaths worldwide can be addressed through rapid delivery of effective emergent care. We propose to establish “Rwanda912” as an innovative mHealth platform to improve the existing prehospital system by accurately locating patients and facilitating communication between dispatch, ambulance and emergency triage staff in Kigali, Rwanda. We hypothesize that this novel platform will be feasible and acceptable to these three stakeholder groups and will improve the delivery of timely and effective prehospital care.